Trackerless Surgical Navigation for Dynamic Environments in Minimally Invasive Liver Surgery

Project Summary/Abstract
The complex variations of the liver during surgical resection present a significant challenge for surgical
navigation in minimally invasive liver surgery (MILS). This proposal aims to revolutionize MILS navigation by
leveraging novel computer vision and deep learning algorithms to integrate multiple imaging modalities, including
regular and near-infrared (NIR) laparoscopy, ultrasound, and MR/CT. Our first objective is to develop a
pioneering dynamic simultaneous localization and mapping (SLAM) approach, enabling real-time tracking of liver
surface variations from stereo laparoscopic videos. To mitigate the accumulative errors during lengthy
procedures, we will utilize near-infrared tattoo technology to establish easily recognizable artificial landmarks.
Our second objective is to develop an efficient 3D ultrasound volumetric reconstruction method and a
comprehensive registration method between SLAM, ultrasound, and MR/CT data to improve the accuracy of
localizing internal vessels and tumors, as well as minimize accumulative errors. Preliminary results have shown
promise, validating the feasibility of our approach. Moving forward, we will integrate these algorithms into the 3D
Slicer software to provide an intuitive interface to surgeons and validate our navigation system using both ex
vivo and in vivo porcine livers.
Our project benefits from a strong research team. Dr. Haoyin Zhou (PI) has extensive expertise in
computer vision and deep learning, underpinning our innovative SLAM approaches. Dr. Jayender Jagadeesan
(co-investigator) brings invaluable experience in surgical navigation, while Dr. Sandy Wells (co-investigator) is a
renowned authority in ultrasound image registration and segmentation. Dr. Jiping Wang (Other Significant
Contributor) contributes extensive expertise as an experienced general surgeon. Together, our team from
Brigham and Women's Hospital, Harvard Medical School, is poised to make significant strides in advancing MILS
navigation.

Public health relevance
Project Narrative This project aims to develop a groundbreaking surgical navigation solution for minimally invasive liver surgery (MILS) by integrating cutting-edge computer vision and deep learning algorithms to track dynamic liver variations in real-time during the resection process. Key components include a novel dynamic SLAM algorithm, advanced ultrasound 3D volumetric reconstruction methods, comprehensive registration algorithms among SLAM, ultrasound, and MR/CT, and near-infrared tattoo technologies. These elements will collectively provide precise, continuous tracking and guidance, enhancing the safety and efficacy of MILS procedures.